At-home computerized assessment of normal cognitive aging and age-related cognitive decline in older African Americans, Hispanics, and rural non-Hispanic whites

Although by 2060 African Americans, Hispanics, and residents of rural communities will constitute the
majority of US patients with Alzheimer’s disease (AD), these populations have long been neglected in AD
research studies and clinical trials. In this large scale fast-track SBIR application, we propose to gather
normative longitudinal California Cognitive Assessment Battery (CCAB) data from 300 healthy older (ages 60
to 89) individuals in each of four underserved populations: (1) African Americans: (2) English-speaking US
Hispanics; (2) Spanish-speaking US Hispanics; and (4) non-Hispanic white (nHW) residents of rural
communities. Participants will be recruited in California and South Texas. We will compare the results from
each group with existing normative data from a primarily suburban white population.
The CCAB includes 34 innovative computerized cognitive tests and questionnaires that utilize cellphone
networks to enable telemedical testing in patients’ homes. CCAB test introductions and test materials are
delivered with AI-enhanced text-to-speech voices and verbal responses are analyzed with consensus
automatic speech recognition (CASR) with unexcelled transcription accuracy. Recruitment is facilitated and
testing throughput is increased because CCAB tests are administered in participants’ homes. The CCAB has
been designed to facilitate translation into other languages. Here, we will test Spanish-speaking US residents
with CCAB-Español, a Spanish version of the CCAB optimized for US Spanish dialects.
During Phase I, we will recruit African American and Hispanic examiners, assure that the Spanish
translation of the CCAB is adapted for the US Hispanic population, and begin testing. During Phase II we will
continue enrollment testing and thereafter test participants at one-year intervals to gather longitudinal norms
and identify performance patterns that predict subsequent cognitive decline. Ethnoracial norms for each CCAB
test will be developed using traditional analysis and supplemented with Item response theory factor analysis to
improve scoring sensitivity and eliminate score bias. The acquisition of normative CCAB data will lower access
barriers to neuropsychological assessment among ethnoracial minorities for six reasons: (1) At-home CCAB
Testing will not be interrupted by COVID-19 lockdowns; (2) At-home CCAB testing minimizes mobility and
transportation challenges; (3) CCAB-Español will address the lack of well-normed, scalable Spanish-language
tests for the US Hispanic population and facilitate access to Spanish-speaking examiners; (4) CCAB
telemedical testing will provide access to cognitive assessments in neglected urban and rural neighborhoods;
(5) CCAB testing can reduce cost barriers to cognitive assessment by more than 70%; (6) The CCAB will
reduce cultural barriers to research participation by testing participants in their familiar home surroundings and
by using ethnoracially sensitive African American and Hispanic examiners.

Public health relevance
Project Narrative Alzheimer’s disease and related disorders (ADRDs) is a health care burden with enormous medical and personal cost that will affect an increasing number of Americans as the population ages. ADRDs disproportionately affect ethnoracial minorities who are expected to constitute half of all ADRD cases in the US by 2060. Unfortunately, the cognitive tests needed to identify at-risk patients are not available in most minority communities who have also been largely excluded from clinical trials evaluating new therapies to slow ADRD disease progression. Here we propose to gather normative data from minority cohorts of English-speaking African Americans and Hispanics, and Spanish-speaking Hispanics using a set of innovative, sensitive computerized cognitive tests that can be telemedically administered in patients’ homes. These studies will facilitate the inclusion of minority populations in clinical trials and, in the future, improve minority access to cognitive testing at substantially reduced costs.